Impact of age on altered steroidogenesis and estrogen receptor activation in benign prostatic hyperplasia progression

Project Summary/Abstract
Candidate: My overall career goal is to become an independent investigator and leader in an aging
related field focused on urologic diseases, especially lower urinary tract dysfunction (LUTD). Benign
prostatic hyperplasia (BPH) is a disease that primarily affects aging men and manifests as urinary dysfunction.
However, the etiology of the disease is complex and multifactorial and the impact of aging on the hormone
environment is often not considered in current research. The overarching goal of my work is to examine the
effects of aging on sex steroid hormones that contribute to the development of disease and identify biomarkers
relevant to disease progression and treatment efficacy. The goal of this K01 career development proposal is to
provide me with the research experience and training needed to become an independent investigator and
leader in the field. My training will be targeted to three key areas: 1) molecular modeling of aging and disease,
2) identification and analysis of peripheral biomarkers, and 3) epigenetic modifiers of the aging steroid
hormone environment. This research experience combined with the mentoring from leading experts at the
University of Wisconsin – Madison will uniquely position me for a successful independent research career.
Research: Benign prostatic hyperplasia (BPH) impacts 50% of men in their 50s but dramatically increases to
90% of men in their 80s with annual treatment costs $4 billion. One consequence of aging in males is altered
steroid hormone synthesis and metabolism that leads to elevated levels of circulating estrogens. Estrogen
signaling through estrogen receptors (ER) within the prostate regulate prostate tissue homeostasis with ERα
associated with proliferation and ERβ with apoptosis. Current BPH treatments target the biosynthesis of
androgens with little consideration for androgen conversion to ER ligands. I hypothesize that selective ER
modulators (SERMs) can reestablish ERα:ERβ homeostasis through ERβ activation and reverse the
impact of ERα-mediated proliferation on BPH progression in the aging male. The critical elements of this
hypothesis will be tested in the following specific aims:
Aim 1: Determine the impact of age-related changes in steroidogenic enzymes required for ERβ ligand
production on prostate proliferation in vitro and in vivo.
Aim 2: Examine the effect of aging on the epigenetic regulation of steroid hormone metabolism and activity.
Aim 3: Evaluate the effectiveness of SERMs to limit hyperplasia in the aging prostate.
The work proposed in these aims is designed to identify potential peripheral biomarkers to aid in assessing and
stratifying BPH patients with age-associated hormone driven hyperplasia. This will allow for the development of
novel combination pharmacotherapies that would enhance the clinical efficacy of current drug treatments.

Public health relevance
Project Narrative/Relevance This project will investigate the impact of aging on sex steroid hormones in benign prostatic hyperplasia (BPH) progression. In better defining the mechanisms of age-related disease progression due to altered steroid hormone metabolism, the reestablishment of steroid hormone homeostasis could provide a novel, effective treatment of BPH.